A Randomized, Double-Blind, Placebo-Controlled Study of LHP588 in Subjects with P. gingivalis-Positive Alzheimer's Disease

SUMMARY/ABSTRACT
A Randomized, Double-Blind, Placebo-Controlled Study of LHP588
in Subjects with P. gingivalis-Positive Alzheimer's Disease
Given the increasing incidence of AD worldwide, there is an urgent unmet need for precision medicine approaches
that could prevent or delay cognitive decline experienced by Alzheimer’s disease (AD) patients. Mounting evidence
suggests that life exposure to brain-penetrant pathogens could contribute to the etiology of AD. One microbial
agent recently associated with AD is Porphyromonas gingivalis (Pg). Pg is best known for its role in chronic
periodontitis , but epidemiologic and other studies also strongly imply its contribution to cognitive decline. Critically,
Pg virulence factors, proteases called gingipains have been identified in post-mortem AD brains, at rates
significantly higher than age-matched controls. Gingipain loads have shown a positive correlation with AD severity,
brain tau levels, and ubiquitin pathology. Our team previously developed a small-molecule, brain-penetrant, orally
bioavailable, first-generation, covalent gingipain inhibitor called COR388 (atuzaginstat), which mitigated many AD-
associated neuropathological features in preclinical in vitro and animal studies. After obtaining U.S. Food & Drug
Administration (FDA) permission, we conducted a large, Phase-II/III, placebo-controlled, randomized clinical trial
of atuzaginstat administered to mild-to-moderate dementia subjects (MMSE ranging 12-24) for 48 weeks. Target
engagement was verified along with dose-dependent reduction of systemic Pg infection. The prespecified
subgroup analysis most relevant to the mechanism of action indicated dose-dependent efficacy in patients
with Pg-positive (Pg+) saliva (N=242), with a reduction of the AD Assessment Scale-Cognitive Subscale 11
(ADAS-Cog11) scores by 57% compared to baseline (p=0.02). However, because of hepatic safety concerns,
development of atuzaginstat was discontinued.
We, at Lighthouse Pharmaceuticals, have now developed a second-generation, orally bioavailable gingipain
inhibitor called LHP588. Rigorous in vitro and animal studies have demonstrated improved target engagement and
reduced toxicity of LHP588 compared to atuzaginstat. In a Phase I study combining a single-ascending-dose and
a 10-day multiple-ascending-dose, LHP588 was well tolerated and there was no evidence of hepatic toxicities at
any dose. Using our experience with atuzaginstat and the development of LHP588, we formulated the hypothesis
that LHP588 can provide increased target engagement with reduced safety risks to slow down cognitive
decline in patients suffering from Pg-positive (Pg+) mild-to-moderate AD. To test our hypothesis, we will
deploy a rigorously designed Phase II, double-blind, placebo-controlled, randomized, 3-arm, parallel group clinical
trial termed SPRING (Stopping PRogression of Porphyromonas gINGivalis-associated AD). Thorough screening
will select AD subjects with Pg+ saliva and plasma p-tau-217 levels above 0.42 pg/mL, which is associated with
amyloid plaque positivity across racial and ethnic groups. Enrolled study participants (N=300; minimum of 30% of
diverse subjects) will be randomized 1:1:1 to 25 or 50 mg LHP588 taken orally once-a-day, or matching placebo,
for 48 weeks. Importantly, the FDA provided a “study may proceed” letter after review of our Investigational
New Drug (IND) application. In Aim 1, we will assess safety and tolerability in AD subjects administered LHP588.
In Aim 2, we will test for target engagement by measuring Pg DNA levels in saliva and anti-Pg IgG levels in serum.
In Aim 3, we will determine drug efficacy vs. placebo using clinical assessments of dementia, i.e., cognition (ADAS-
Cog11, which is the primary efficacy measure), other clinical measures, biomarkers, including brain atrophy
estimated by vMRI, and plasma levels of p-tau-217. Success of our SPRING trial will warrant carrying out at least
one larger confirmatory Phase III study for future FDA approval.

Public health relevance
NARRATIVE A Randomized, Double-Blind, Placebo-Controlled Study of LHP588 in Subjects with P. gingivalis-Positive Alzheimer's Disease The present project is a rigorously designed Phase II, double-blind, placebo-controlled, randomized, 3-arm, parallel group clinical trial termed SPRING (Stopping PRogression of Porphyromonas gINGivalis-associated AD). Our second-generation lysine-gingipain inhibitor LHP588 will be administered to AD subjects with Pg+ saliva and elevated plasma p-tau-217. Study participants (N=300) will be randomized 1:1:1 to 25 or 50 mg LHP588 taken orally once-a-day, or matching placebo, for 48 weeks. Our primary efficacy measure is ADAS-Cog11 scores.